Molecular mechanism of NLRP3 inflammasome activation

Project Summary
NACHT, LRR and PYD domains-containing protein 3 (NLRP3) is a critical component of the
innate immune system that forms the NLRP3 inflammasome, an intracellular molecular platform
that drives caspase-1 activation and the secretion of biologically active IL-1β and IL-18. In addition
to its protective role in innate immunity, aberrant activation of the NLRP3 inflammasome
contributes to the pathogenesis of several inherited and acquired inflammatory disorders, such
as Cryopyrin-associated autoinflammatory syndrome, gout, Crohn's disease, Alzheimer's
disease, diabetes and atherosclerosis. Despite extensive investigation, the molecular mechanism
leading to NLRP3 inflammasome activation remains elusive. Recently, the protein kinase Nek7
has been found to mediate NLRP3 inflammasome activation independently of its kinase activity.
However, it is unknown how Nek7 is mechanistically linked to NLRP3 inflammasome activation.
Our recent studies implicate a critical role for Nek7 phosphorylation in NLRP3 inflammasome
activation. In this application we aim to elucidate the molecular mechanism of Nek7-mediated
NLRP3 inflammasome activation and determine the role of a novel regulator in this pathway. Our
results are expected to provide new mechanistic insights into NLRP3 inflammasome activation
and might guide the development of novel therapeutic strategies for treating NLRP3-driven
inflammatory diseases.

Public health relevance
Project Narrative Aberrant activation of the NLRP3 inflammasome contributes to the pathogenesis of several inflammatory disorders, including Cryopyrin-associated autoinflammatory syndrome, gout, diabetes, and Alzheimer's disease. The goal of this application is to better understand how the NLRP3 inflammasome is activated. Understanding the mechanism of NLRP3 inflammasome activation might guide the development of novel therapeutic strategies for treating inflammatory diseases.